Adaptation of Family Check-Up Online in the Latinx Community to Reduce Youth Substance Use.

7. PROJECT SUMMARY
Latinx people are the largest and fastest growing minority population in the U.S., yet most lack access to
culturally responsive preventative interventions to reduce substance use among youth. Effective
implementation of evidence-based interventions that can be delivered online is critical to reduce substance use
and problem behaviors among ethnic minority populations and to scale up for broad dissemination. Cultural
adaptation has improved parenting practices and youth outcomes beyond the original evidence-based
parenting interventions, and culturally adapted parenting programs have the potential to improve cultural
socialization, which is associated with improved behavioral outcomes among Latinx youth. However, ongoing
tensions in the field highlight the question of whether deep cultural adaptations compared to surface-level
adaptations (e.g., translation only) are needed. The FCU is an evidence-based parenting program that has a
strong history of reducing substance abuse and externalizing symptoms (e.g., problem behaviors). A
community-based participatory approach will be employed to culturally adapt the FCU Online and identify
implementation strategies to improve access to and adoption of the intervention, leveraging community and
cultural resiliency-promoting assets. Promotores de salud, Spanish-speaking community health workers in an
existing community-based research network will deliver the program. To reach the goals of the study, the
following aims will guide this research. In Aim 1, a community advisory board of 6 parents and 6 promotores de
salud will meet monthly to guide the ecological, cultural adaptation of the FCU Online modules and
implementation strategies with promotores. In Aim 2, the online version of the intervention will be adapted
using iterative Plan-Do-Study-Act cycles to get usability feedback from members of the community advisory
board, consistent with best practices designed to adapt interventions in community settings. In Aim 3, using a
Hybrid 1, mixed methods design, researchers will assess feasibility, accessibility, adoption, and potential
effectiveness of the adapted intervention, FCU-L Online. The team will recruit 96 Latinx families into a 3-arm
wait-list randomized control trial: n=32 in the culturally adapted FCU-L Online (e.g., deep adaptation), n=32 in
the FCU Online in Spanish without adaptation (e.g., surface level adaptation), and n= 32 in a waitlist control
group. Feasibility, accessibility, and adoption will be assessed according to quantitative benchmarks, and
qualitative feedback will assess the barriers and facilitators of implementation. Potential effectiveness will be
assessed, including improvement of key intervention mechanisms (parenting practices, parenting efficacy, and
cultural socialization) as well as child outcomes (substance use, intentions to use, and externalizing behavior).
Findings from this study will inform a Hybrid II randomized controlled implementation trial to test effectiveness
while scaling up dissemination of the FCU-L Online. This research could ultimately reduce lifetime risk for
substance use among Latinx youth by improving parenting practices and supporting cultural socialization.

Public health relevance
8. PROJECT NARRATIVE The goals of this study are to culturally adapt the online version of the Family Check-Up and identify strategies to reduce barriers to engagement and support effectiveness through a community-engaged approach. We will integrate iterative feedback from a community advisory board into the adaptation of the online model. Our team will assess feasibility, accessibility, adoption, and potential effectiveness, with the goal of targeting key parenting mechanisms (parenting practices and cultural socialization) to reduce substance use risk among Latinx youth and inform broad public health efforts to prevent substance abuse.